Platelet Reprogramming During Inflammation

Inflammation and sepsis are characterized by dysregulated host responses that span hemostatic, inflammatory,
and immune continuums. Thrombosis is a common complication of sepsis, contributing to adverse outcomes
including organ failure and death. The significance of these dysregulated host responses is demonstrated by
studies suggesting half of all hospital deaths, including Veterans, may be attributed to sepsis. Sepsis also
increases the long-term risk of cardiovascular disease and stroke, and causes substantial morbidity among
Veteran patients. Established and emerging evidence supports the concept that dysregulated platelet responses
mediate thrombotic events during inflammation, including sepsis. Nevertheless, the molecular mechanisms and
functional consequences of dysregulated platelet functions during sepsis remain incompletely understood. Our
proposal, entitled “Platelet Reprograming During Inflammation” will identify new pathways by which interferon
alpha (IFN), which is systemically increased during sepsis, regulates the loading, trafficking, and secretion of
cargo proteins in platelets and their parent cell, megakaryocytes (MKs). We have identified that the expression
of interferon-induced transmembrane protein 3 (IFITM3) is robustly induced in platelets and MKs during
inflammatory stress. Our preliminary data also suggest that increased IFITM3 in platelets regulates the secretion
of cargo proteins to promote a thrombo-inflammatory milieu. In this proposal, we will perform complementary
clinical, ex vivo, and in vivo studies to determine how IFITM3 governs cargo loading, trafficking, and secretion in
platelets and MKs during inflammation. In specific aim 1, we will determine whether or not IFITM3 regulates
cargo granule secretion during inflammation and identify proteins that IFITM3 interacts with. We will also examine
the effects of a naturally-occurring, loss of function mutation in IFITM3 on secretion. In specific aim 2, we will use
complementary pharmacologic and genetic toolsets to determine if IFITM3 regulates cargo loading and
trafficking in platelet granules during inflammation. In specific aim 3, we will establish how IFITM3 participates in
inflammatory and thrombotic host responses during sepsis. These studies are innovative as IFITM3 has not
previously been identified as a regulator of cargo movement within platelets and MKs, or any other cell
for that matter. Regulated cargo movement is critical for proper cell functions and disrupted cargo
movement contributes to inflammation and thrombosis in many diseases. This work will therefore test an
important functional hypothesis and elucidate completely new pathophysiologic mechanisms of thrombosis
during inflammation and sepsis. This proposal will help us understand how interferons contribute to
sepsis-associated thrombosis (a disease affecting thousands of Veterans each year), and may elucidate
new therapeutic avenues to prevent these thrombotic complications. Discoveries made may also help
us understand the basis for thrombosis that occurs in other thrombo-inflammatory diseases affecting
Veterans (e.g., cancer, cardiovascular disease, others). Findings generated from our studies will also likely
have relevance across other cell types, as IFITM3 is ubiquitously expressed and regulated cargo movement is
critical for the function of most human cells.

Public health relevance
Thrombosis, or blood clots, complicates inflammatory syndromes such as sepsis, and may contribute to organ failure and death in Veterans. Sepsis is caused by infections, including bacteria and viruses. Sepsis can result in widespread inflammation and, in severe cases, death and disability. Small circulating cells in the bloodstream, called platelets, mediate inflammation and blood clotting during sepsis. We have found that sepsis increases interferon-responsive genes in platelets and their parent cells, megakaryocytes. Interferon is an inflammatory cytokine that is usually increased during sepsis. We have also found that one of these interferon-regulated genes, called IFITM3, controls the movement of proteins in platelets and megakaryocytes. Our studies will examine how IFITM3 controls protein movement in cells to regulate blood clotting during inflammation and sepsis. Our research will help us understand why blood clotting occurs in Veterans during sepsis and other inflammatory diseases. We may also find new ways to prevent blood clotting from occurring.